Replacement of Fluorescence Imaging System

PROJECT SUMMARY
The central aim of the parent grant is to develop an assay for genome-wide identification of pairing
interactions between homologous DNA segments. Juxtaposition of homologous DNA sequences is a key
determinant of chromosome structure, genome stability and gene expression control. In somatic cells,
pairing between sister chromatids ensures accurate chromosome break repair and chromosome
segregation. In the germ line, pairing between homologous chromosomes ensures genome haploidization
for sexual reproduction. During development, interactions between homologous chromosome segments
are required for establishing monoallelic gene expression. Pairing defects are associated with
chromosome missegregation, genome rearrangements and aberrant gene dosage, resulting in birth
defects, cancer, and premature aging. Developing an assay that identifies genome segments involved in
homologous pairing is an essential step for a mechanistic understanding of this process. In the parent
grant, we are developing the Homolog Pairing Capture assay, to quantitatively detect homologous DNA
interactions. While applicable to a large number of developmental stages and organisms, we are using
budding yeast meiosis as a model system for assay development. Synchronous meiosis can be induced in
yeast cultures in millions of cells, facilitating the capture of cells at the stage of genome-wide homologous
pairing. Many of our approaches involve monitoring of meiotic cell cycle progression via fluorescence
microscopy. In this supplement proposal, we are requesting funds for a replacement for our aging routine
fluorescence microscope and a sensitive camera integrated with an up-to-date imaging system. Our
current system has become unreliable and is near the end of its lifetime. An updated fluorescence
microscope will enable us to maintain and further enhance a high-impact research program into
mechanisms of homologous chromosome pairing.

Public health relevance
Narrative Similar or identical DNA sequences along chromosomes have an impressive ability to find and interact with each other. Defects in such homologous DNA interactions may result in cell senescence, cancer, and reproductive failure. Our work will generate an assay that identifies sites of homologous DNA interactions along the entire genome of intact cells, thereby allowing diagnosis of mistakes in DNA interactions under pathological conditions.